Optical Microscopy Core

PROJECT SUMMARY: OPTICAL MICROSCOPY CORE
The objective of the C-SiG Optical Microscopy Core, is to be a state-of-the-art, user-friendly service that
connects investigators with the many optical technologies and applications at a reasonable cost. Under the
direction of Dr. Mark McNiven, a well-established cell biologist, the Core integrates existing resources from
individual investigators in the Division of Gastroenterology and Hepatology (GIH) with new equipment added
during this funding cycle (histology, live cell imaging, and lightsheet microscopes). The C-SiG Optical
Microscopy Core also collaboratively partners with the Mayo Microscopy and Cell Analysis (MMCA) Core to
enhance resources available to center members by providing GI-relevant expertise and training for C-SiG
members. The Specific Aims of this core are three-fold. First, to provide reliable, accessible, state-of-the-art
microscopic technology to all C-SiG members that will facilitate their study of GI cellular signaling cascades.
Second, to educate and train C-SiG members in the use of both basic and sophisticated cellular imaging
methods. Emphasis is placed on providing technical instruction as well as educating faculty on how such
approaches can expand the scope and breadth of their scientific programs. Third, to develop and apply state-
of-the-art optical imaging technologies, including fluorescent probes, vital dyes, and biosensors, to study GI
tissues and/or cells. The most popular Core service is access to the well-maintained C-SiG Confocal
Microscopes, for which utilization has more than doubled in the past 4.5 years. The Core also provides
instruction, technical advice, data interpretation, and development of novel, innovative optical approaches to
the study of signaling pathways in GI cells and tissues. These services cover a wide range of topics including:
real-time computer/video imaging of live cells; confocal microscopy coupled with computer-based 3-D image
reconstruction; Fluorescence Resonance Energy Transfer (FRET) applications to measure dynamic protein-
protein interactions; Fluorescence Recovery After Photobleaching (FRAP) that allows the quantitation of
protein recruitment/turnover; Fluorescence Loss in Photobleaching (FLIP); microinjection of living cells;
expression and use of fluorescence-based bioprobes that facilitates the study and localization of specific
signaling molecules including both proteins and lipids; the development and application of specific photo-
activatable caged-compounds that allow a precise temporal and spatial activation of desired signaling
molecules in live cells; Total internal reflection (TIRF) microscopy; multiphoton microscopy, and super-
resolution microscopy. Over the past 4.5 years, the C-SiG Optical Microscopy Core has provided services to
55 members [47 current members (69% of current membership)] and supported 133 publications.